Leveraging Artificial Intelligence to Predict Mental Health Risk among Youth Presenting to Rural Primary Care Clinics

PROJECT SUMMARY
This study, in response to RFA-MH-25-195, aims to enhance, deploy, and rigorously validate the Duke
Predictive Model of Adolescent Mental Health (Duke-PMA), which uses a novel clinical signature derived from
affordable, accessible measures to identify youth at high risk for psychiatric illness in primary care settings.
The Duke-PMA, a neural network-based predictive tool, has already demonstrated high accuracy in predicting
psychiatric risk one year in advance in youth aged 10-15, using data from the Adolescent Brain and Cognitive
Development (ABCD) study. Notably, sleep disturbances have emerged as a key modifiable predictor in the
model.
Unlike most predictive models that rely on current symptoms to anticipate outcomes, the Duke-PMA bases
its predictions on underlying disease mechanisms and protective factors, making it better suited to inform
preventive interventions. Furthermore, the model identifies an elevated p-factor, a general measure of
psychopathology that spans multiple psychiatric conditions, making it broadly applicable across diverse youth
populations.
Our project will begin by optimizing the Duke-PMA through the incorporation of behavioral tasks from the
NIH Toolbox to enhance its prediction performance. Following Duke AI Health’s Algorithm-Based Clinical
Decision Support Oversight framework, we will ensure the model adheres to the highest standards of
transparency, quality, and equity. Additionally, we will apply trustworthy AI techniques designed to reduce effects
of distribution shifts on model performance to ensure the model remains effective and equitable across diverse
clinical settings and demographic groups. After optimization, the Duke-PMA will be deployed in rural primary
care and pediatric clinics, where access to mental health services and research participation is often limited. We
will enroll 2,000 youth from rural clinics in the Southeast and Midwest, partnering with the Science, Technology,
and Research (STAR) Clinical Research Network. We will also explore the benefit of adding a measure of home
environments to the Duke-PMA through digital envirotyping, which uses an AI-driven approach to assess home
environments remotely without requiring in-person visits, making it much more resource-efficient and accessible
than current approaches. Model performance will be validated through psychiatric diagnostics conducted one
year after the initial assessment.
If successful, this project has the potential to transform mental health resource allocation particularly in
underserved communities by offering an accessible, low-cost, data-driven approach to identify vulnerable youth
and highlight modifiable risk factors for early intervention.

Public health relevance
PROJECT NARRATIVE This study will enhance, deploy, and rigorously validate the Duke Predictive Model of Adolescent Mental Health (Duke-PMA), which will use a novel clinical signature derived from accessible, low-cost clinical and behavioral measures to identify youth at high risk for psychiatric illness in rural primary care settings. The Duke-PMA uses a mechanistic approach to predict general psychiatric risk (p-factor) based on modifiable factors, and thus can be used by providers not only to identify high risk youth, but also to select appropriate preventive strategies, thereby promoting optimal allocation of limited resources. The study will enroll 2,000 youth (ages 10-15) from rural clinics and apply trustworthy model evaluation practices to validate model performance through psychiatric diagnostics while ensuring equitable performance across diverse populations.